Improving Non-Viral Gene Delivery, Integration, and Expression Methods for Cell Therapies

PROJECT SUMMARY
Since 2017, six CAR-T cell therapies and four hematopoietic stem cell (HSC) therapies have been approved in
the U.S. and E.U. to treat cancers, hemophilia, ALD, MLD, and ADA-SCID. These therapies use a lentivirus (LV)
to efficiently deliver and integrate a therapeutic gene into the host cell genome, but LVs are expensive to produce
and their semi-random genomic integration patterns have been shown to induce cancer in some patients (e.g.,
3/67 patients treated with SkysonaTM). Therefore, while LV is a highly efficient gene delivery vehicle, its
disadvantages have motivated the search for alternative non-viral gene delivery (NVGD) methods.
The goal of this collaborative multi-PI proposal is to develop NVGD methods that are less expensive and safer
than LV, while achieving comparably high levels of transgene expression. In Aim 1, the Bracaglia lab will develop
novel polymeric gene delivery vehicles that maximize the delivery of siRNAs (or other cargoes) to T cells and
HSCs. In Aim 2, Drs. Elmer and Huang will collaborate to discover and test novel drugs that temporarily inhibit
host cell proteins that repress foreign genes. Finally, the Elmer lab will optimize the non-viral integration of
transgenes in Aim 3 by identifying the safest and most effective sites for transgene integration in the T cell and
HSC genomes.
Altogether, these efforts will result in the development of novel NVGD methods that significantly improve a wide
range of current and future gene therapies and provide a holistic research experience in cellular engineering for
at least 18 undergraduate students that will work on this project as part of our Senior Project Studio (SPS), in
which students will work with the PIs on the proposed projects in Aims 1-3 for course credit. In addition, the PIs
will also involve dozens of additional students in the project by designing relevant hands-on research projects
that will be incorporated into six lab and lecture courses that are taught by the PIs.

Public health relevance
PROJECT NARRATIVE Current cell therapies use a lentivirus to effectively deliver therapeutic genes to T cells and HSCs, but this strategy can be expensive and potentially hazardous. The goal of this project is to optimize the non-viral delivery, integration, and expression of genes in T cells and HSCs to provide a safer and less expensive alternative to viral gene delivery. Eighteen undergraduate students will be recruited to participate in this project as part of Villanova’s Senior Project Studio (a 2-semester research for credit course), while the PIs will also use the data and methods developed in this project to develop group projects and other learning experiences for dozens of other students in their lecture and lab courses.